Georgia Science Education Initiative NCI YES (GA-YES)

Project Summary/Abstract
While the racial and ethnic diversity of the US has increased over time, the diversity of those involved in cancer
and biomedical research has not reflected the overall US population; only about 11% of researchers overall are
from racial/ethnic minority groups. These under-represented groups include women; Blacks/African Americans;
Hispanics or Latinos; those with disabilities; residents of rural or medically underserved area; students from lower
socio-economic status (SES) or are first in their families to attend college. Rural students, in particular, represent
only 3 out of every 10 students pursuing STEM careers and their families tend to come from lower SES and less
education. Rural students begin high school with the same interest in STEM as students from higher SES
suburban schools but often decrease interest by junior year. The importance of community is not consistently
included in pipeline programs; yet, many of the communities where under-represented students reside will
experience significant cancer disparities. Thus, the goal of pursuing cancer research to reduce disparities in their
community may be highly relevant. In this Georgia Science Education Initiative NCI YES (GA-YES) program,
the theme of cancer disparities will be integrated into all student research projects, the curriculum development
process, and community outreach and engagement components. Based upon these concepts, our hypothesis
is that by focusing on cancer disparities that impact the students’ own communities, this approach will enhance
student motivation to continue to pursue future STEM/biomedical studies in higher education and ultimately, in
a future career in cancer research. By exploring the underlying mechanisms, epidemiology, risks, and potential
interventions that might affect these disparities, this approach would serve to engage students more deeply and
demonstrate the applicability of the science and research to the student’s own community setting. To investigate
this hypothesis, our Specific Aims are: Aim 1: To recruit high school students under-represented in STEM
careers from six high schools located in a rural, persistent poverty county in Georgia to participate in a summer
mentored cancer research training program focused on cancer disparities at the Winship Cancer Institute of
Emory University. Aim 2: To develop and test an accompanying curriculum focused on cancer science, research
skills, health equity and career development that engages students all year-long. Aim 3: To facilitate student
outreach and engagement with communities to receive feedback related to research projects and educate
community stakeholders about cancer research, including clinical trials. Aim 4: To evaluate short- and long-term
program outcomes, student characteristics, and track student participants for 15 years post-enrollment to assess
primary outcomes (pursuing a career in cancer research or biomedical sciences).The impact of this proposal
will be in contributing long-term program evaluation with measurable outcomes for best practices in building a
diverse future workforce for cancer and biomedical research careers, by integrating cancer disparities into
research training, with a novel focus on under-represented rural and lower SES students.

Public health relevance
PROJECT NARRATIVE This educational research program targets high school students from a rural, lower socioeconomic status area to promote a more diverse future biomedical workforce. Faculty-mentored research projects, development of a training curriculum, bi-directional feedback with community stakeholders, undergraduate mentors, community education, and integration of cancer disparities throughout all aspects of the program are highlights of the proposal. Program evaluation, including tracking students 15 years to determine future career pursuits, is emphasized.